Dynamin function in pancreatic beta-cell autophagy

PROJECT SUMMARY
Diabetes affects over 30 million Americans, yet its epidemic is still rising at an alarming rate. The
progressive decline of pancreatic β cell function and mass is a hallmark of diabetes, but no medications
prevent this decline. Interestingly, a fasting-mimicking diet known to activate autophagy stops this
decline and reverses diabetes in mice. Accordingly, recent progress has increasingly recognized
autophagy as a potential therapeutic target to treat diabetes because of its role in protecting β cells
against pathogens and metabolic stress. However, the basic nature of β cell autophagy remains poorly
understood, particularly in the molecular process governing autophagic membrane fission. Our recent
data uncover that dynamin, a subfamily of large GTPases known to regulate endocytosis and insulin
secretion, directly alters β cell autophagy. Live-cell imaging suggests that dynamin molecules can
translocate to autolysosomes and drive autolysosome fission. Dynamin deletion causes striking
autophagy defects in β cells in vitro and in vivo. These new findings fuel tremendous interest in
understanding the molecule mechanisms at play throughout the β cell autophagy cycle. We
hypothesize that dynamin plays a direct and crucial role in β cell autophagy flux that has not been
characterized previously. Mechanistically, we suspect that dynamin regulates β cell autophagy through
regulating autolysosome fission and autophagic transport. These processes may be essential to protect
β cells against chronic metabolic stress toward diabetes. To test the hypothesis, we have generated
dynamin isoform-specific mouse models, which allow evaluating dynamin-regulated β cell autophagy
and its protection against metabolic stress associated with diabetes. We have assembled a team with
substantial expertise in β cell biology, super-resolution imaging, biochemical signaling, and diabetes.
We will focus on three specific aims. First, define the role of dynamin in β cell autolysosome fission.
The fission step is necessary for autolysosome-to-lysosome transformation in each autophagic cycle
of β cells, but its mechanism remains poorly understood. Second, identify the role of dynamin in
regulating autophagic transport via microtubule modulation. This aim may uncover a previously
unappreciated pathway for dynamin to regulate autophagy in β cells. Third, examine how dynamin
regulates β cell autophagic responses upon metabolic stress in vivo. Together, these studies will
provide new insights into the autophagic turnover in β cells and its regulation by different dynamin
isoforms. The results will advance the fundamental understanding of β cell autophagy cycles that
profoundly impacts islet function and diabetes pathogenesis.

Public health relevance
PROJECT NARRATIVE Targeting pancreatic β cell autophagy can potentially restore insulin secretion and reverse diabetes, but we know little how autophagy operates in β cells. Our preliminary data suggest that a subfamily of large-GTPase dynamins (dynamin-2 and dynamin-3) regulate β cell autophagy, a process known to protect β cells against metabolic stress. We will investigate the underlying molecular mechanisms using advanced imaging techniques, biochemistry assays, and unique genetic models to understand dynamin-regulated β cell autophagy in healthy conditions and under diabetic stress.